FUNCTION OF DENGUE VIRUS NONSTRUCTURAL GLYCOPROTEIN NS1 DURING VIRUS REPLICATION

Two studies have been initiated to study the role of NS1 in the dengue virus life cycle. The first is the introduction of mutations into the full length dengue 2 clone. In vitro transcribed RNA from mutant and full length cDNA clones is transfected into susceptible LLC-MK2 cells. At times post-transfection, virus replication is assayed by analyzing viral antigen production and viral RNA replication. A mutant which contains a forty amino acid deletion in the NS1 open reading frame will not replicate in LLC-MK2 cells. The second study is the establishment of LLC-MK2 cells expressing NS1. These cells express low levels of dengue 2 NS1. Cells expressing NS1 are able to complement NS1 mutant dengue 2 genomes. These cells will be used to make stocks of mutant virus, and to study the processing and secretion pathways of NS1.